Development of a School-Based Prevention Intervention to Promote Adolescent Mental Health Equity

Project Summary
Background/Objective: Transgender adolescents experience significant mental health inequities identified as
a critical health concern by the NIH, IOM, and CDC. These inequities are largely attributable to transgender
adolescents’ exposure to discrimination in multiple places, including at school. Gender-affirming school
practices, which supportively address the needs and experiences of transgender students (e.g., teachers using
students’ affirmed name/pronouns), have been shown to mitigate mental health problems (e.g., depression,
anxiety) for transgender adolescents. Despite calls from the US Department of Education to increase
gender-affirming practice implementation in schools, few if any evidence-based resources exist to support
practice adoption. To address this need, this study will refine and evaluate the effectiveness and
implementation of a primary prevention intervention called “Gender-Affirming School Practices (GASP),”
designed to promote healthy emotional and behavioral development in transgender adolescents.
Aim 1: Refine the GASP online training to enhance its usability and acceptability using human-centered design
methods, specifically usability testing, with target users (i.e., school staff).
Aim 2: Develop a scalable implementation blueprint for GASP, defined as a comprehensive plan including
implementation strategies (i.e., beyond the online training) and other key elements (e.g., goals, timeframe)
needed for GASP adoption.
Aim 3: Pilot the GASP intervention and GASP implementation blueprint in a randomized hybrid
effectiveness-implementation type 2 trial in 6 large public high schools. School staff changes in knowledge,
attitudes, and self-efficacy using GASP (hypothesized implementation mechanisms) and increased GASP
adoption (implementation outcome) will be examined. Effectiveness of GASP will be assessed by examining
whether GASP adoption by school staff (implementation outcome) is associated with improvements in
transgender adolescents’ internalized transphobia, negative expectations for future events & non-affirmation
experiences (effectiveness mechanisms) and mental health (effectiveness outcomes; e.g., depression,
anxiety). School- and county-level factors (e.g., structural transphobia) will be explored as potential moderators
of GASP implementation and effectiveness. Results will inform a fully-powered hybrid type 2 trial.
Public Health Impact: GASP represents a feasible and scalable prevention program for improving the mental
health of transgender adolescents. Identified implementation strategies and associated mechanisms may be
generalizable to school-based interventions for other populations facing mental health inequities.

Public health relevance
Project Narrative Transgender adolescents face a disproportionately high risk for serious mental health problems largely attributable to discrimination in multiple places, including at school. Gender-affirming school practices supportively address the needs and experiences of transgender students (e.g., teachers using students’ affirmed name/pronouns) and have been shown to mitigate mental health problems for transgender adolescents. This study will refine a scalable universal school-based prevention intervention to support transgender adolescents' mental health, develop a scalable implementation blueprint, and pilot the intervention and implementation blueprint in a cluster randomized hybrid type 2 effectiveness-implementation trial.